EPSTEIN-BARR VIRUS IN PERIPHERAL BLOOD OF LUNG TRANSPLANT PTS

The purpose of this research study is to develop a blood test which may help to identify transplant patients who are at increased risk for or in the early stages of developing post-transplant lymphoproliferative disorder (PTLD). PTLD is a disease of patients who have received organ transplants, usually occurs within the first six months following transplant surgery and is related to infection with a common virus. Patients with PTLD develop lesions with many of the features of malignant lymphoma (a tumor of white blood cells). However, unlike malignant lymphoma, PTLD can sometimes be cured by changing dosages of anti-rejection medications, without the use of chemotherapy. It is hoped that by identifying the earliest stages of the disease that a higher percentage of patient can be cured.